BIOMARKER CORE

In previous grant cycles, the ADCS has not played a major role in biomarker measurement; assays for Apolipoprotein E (ApoE) genotype, and for plasma and CSF measurement of amyloid peptides and tau proteins have been subcontracted to companies or external academic labs. However, the importance of biomarker measurement has grown steadily, in part due to the success of the Alzheimer's Disease Neuroimaging Initiative. There have been an increasing number of requests for stored ADCS samples, and increasing requests for biomarker measurement from ADCS investigators. To meet these needs, in late 2008, we established a Biomarker Core which is located on the 3rd floor of the Medical Teaching Facility building at UCSD School of Medicine.

Public health relevance
The goal of the laboratory is to identify biomarkers for preclinical AD and better understand how treatment parameters may impact these biomarkers. In addition to playing a role in ADCS clinical trials, another objective of the Biomarker Core is research based and aims to identify and characterize novel biomarkers of AD. The primary focus of this research is on plasma beta-amyloid.